"ISO-ANTIGENIC TYPING OF MOUSE STRAINS"

Exchange reciprocal skin grafts between NIH reference mice and corresponding NCI contractor subline. Perform an estimated 5,500 skin grafts involving 2,600 animals annually. Observe mice at approximately two (2) week intervals for 90 days. Receive all animals for skin grafting purposes. These animals are shipped from breeder colonies as scheduled by the Project Officer and will be sent prepaid on a bi-weekly basis.